Investigation of the mechanisms of H-ARS mitigation by the orally administrated GI-ARS mitigator LR-IFN-beta

Abstract
We have developed a genetically modified second-generation probiotic for the localized delivery of a known
mitigator to the GI tract in order to reduce damage and regenerate tissue after exposure to ionizing radiation.
Mitigating the effects of ionizing radiation exposure is critical for improving survival in the event of a radiological
or nuclear (RAD-NUC) incident, where exposure could lead to hematopoietic or gastrointestinal (GI) acute
radiation syndrome (ARS). While Neupogen and Neulasta have been granted label extensions by the FDA to
treat casualties of a RAD-NUC incident, these drugs do not prevent GI-ARS-related mortality. There currently
are no FDA-approved mitigators for GI-ARS. To address this critical need, we have engineered
Limosilactobacillus reuteri to produce the therapeutic cytokine INF-β and target the mitigator to the small
intestines to recover intestinal stem cells, regenerate the radiation-sensitive intestinal crypts, and dramatically
improve survival from 0–10% to 70–80% after exposure to both GI-ARS and H-ARS-inducing radiation doses.
This is a new strategy for therapeutic drug delivery, using a probiotic that can be administered orally,
facilitating its use in the context of a resource-limited mass casualty scenario. In addition to mitigating
acute injury following a RAD-NUC incident, this approach is also applicable to radioprotection of the intestine
during abdominal radiotherapy. Symptoms of GI toxicity affect 60–80% of the >300,000 patients that receive
pelvic or abdominal radiation therapy per year. This project is based on an entirely new concept that
addresses the fundamental major limitations associated with delivery of any potential radiation mitigator of GI
syndrome, including (i) non-invasive administration, (ii) targeted delivery of the therapeutic, (iii) maintained
bioavailability of the therapeutic at efficacious dose, (iv) trivially scalable to produce, and (v) no need for
formulation. The goal of this project is to develop an FDA-approved mitigator for radiation-induced
hematopoietic and GI injury. As part of this overall effort, we propose critical studies to begin to characterize the
mechanism by which this orally administrated GI-ARS countermeasure is able to mitigate radiation toxicity in the
bone marrow for animals exposed to total body irradiation.

Public health relevance
Project Narrative Mitigating normal tissue toxicity after exposure to ionizing radiation is critical to reduce mortality and morbidity, both for patients that receive pelvic or abdominal radiation therapy, and in the context of a RAD-NUC incident. We have developed second-generation probiotics engineered to express the therapeutic cytokine INF-β that has been shown to increase survival from 0–10% to 70–80% after exposure to a lethal dose of ionizing radiation. The goal of this project is to elucidate the mechanisms by which this drug mitigates radiation damage to the hematopoietic system as part of regulatory approval under the Animal Rule. If successful, this drug development effort will lead to the only FDA-approved radiation mitigator for GI toxicity.